Mesenchymal cell plasticity and signaling in lung regeneration

PROJECT SUMMARY
Regeneration of the lung following severe injury is an imperfect process and frequently leads to permanently
altered lung structure and dysplastic cell types. After severe injury, such as influenza or COVID-19, the alveolus
can either regenerate in form and function (adaptive regeneration) or be replaced by airway-derived dysplastic
epithelium (maladaptive repair). These maladaptive cells and structures do not participate in gas exchange and
likely contribute to the long-term reduction in pulmonary function seen in some patients from severe lung injury,
highlighting the need for the development of new therapeutics with which to promote functional adaptive alveolar
regeneration. Developing these new therapies will require a comprehensive understanding of not only the
progenitor cells and their functions after injury, but also how they signal and interact with other cells within the
injured alveolar niche.
The alveolus is composed of a fragile layer of epithelium surrounded by a dense network of mesenchymal cells
which serve important roles in paracrine signaling within the alveolar niche. Recent work from our lab and others
has demonstrated the heterogeneity of these cells, identifying two key populations of alveolar mesenchyme,
those that express Pdgfra (alpha+) and those that express Pdgfrb (beta+). Based on my extensive preliminary
data demonstrating a key role of alpha+ cell proliferation, plasticity, and Notch signaling in alveolar regeneration
after viral injury in both mouse and human lungs, I will test the hypothesize that specific mesenchymal cell
lineages that arise from injury-induced plasticity establish and maintain the maladaptive epithelial regenerative
response, in part through Notch mesenchymal-epithelial signaling. In Aim 1 of this proposal, I will examine how
alpha+ cell proliferation and plasticity are defined and maintained after viral injury. The proposed research in Aim
1 will further develop my skills in transcriptomic and epigenomic analyses and physiological impacts of injury on
lung function. In the independent phase outlined in Aim 2, I will define the importance of Notch mediated
mesenchymal paracrine signaling within the alveolar niche during adaptive vs maladaptive regeneration. My
primary mentor, Dr. Edward Morrisey is an internationally renowned lung biologist who has identified many key
cell types and pathways which drive regeneration of the injured lung. I have also assembled a diverse advisory
committee of experts in bioinformatics, epigenetics, physiologic readouts of recovery of lung function after injury,
and Notch signaling who will assist me in training of these areas. The proposed work will be conducted at the
University of Pennsylvania, where I will benefit from the rich intellectual environment, wide-ranging resources,
collaborative scientific community in pulmonary and mesenchymal biology, and the full support of the institution.
Together, this proposal outlines a rigorous research and training plan that will establish the foundation to advance
my career in lung and mesenchymal cell biology.

Public health relevance
PROJECT NARRATIVE Regeneration of the distal lung following severe injury (e.g. influenza or COVID-19) is an imperfect process, and frequently leads to permanently altered lung structure and chronic reduction in gas exchange function highlighting the need for a better understanding of alveolar regenerative processes. This proposal investigates how distinct mesenchymal lineages in the lung contribute to lung regeneration through their plasticity and signaling with other cells in the regenerating alveolar niche. The work that will arise from this proposal will enhance our understanding of the role of mesenchymal cells in lung regeneration and identify mechanisms which can be harnessed in the future to develop new therapies for patients with chronic lung disease.